Development of Kv3.1 potentiators for correcting fast-spiking-interneuron hypofunction in schizophrenia and autism spectrum disorder

SUMMARY
Genetic mutations or environmental insults that impair development of neural circuit connectivity can lead to
autism spectrum disorder (ASD) and schizophrenia, which together affect the quality of life, independence, and
productivity of millions of Americans and cost hundreds of billions of dollars annually. ASD and schizophrenia
are associated with an increased ratio of excitatory-to-inhibitory (E/I) synaptic transmission, raising the possibility
that drugs that are capable of restoring E/I balance could treat both disorders. GABAergic parvalbumin-
expressing fast-spiking interneurons (PV-INs) play critical roles in regulating inhibitory output in striatal networks
and coordinating high-frequency oscillations underlying cognition, sensory information processing, motor
behavior, and behavior, which are frequently disrupted in ASD and schizophrenia. The ability of PV-INs to fire
high-frequency action potentials (APs) is dependent on the expression of the voltage-gated potassium (K+)
channel Kv3.1, whose expression is largely restricted to PV-INs. De novo mutations in Kv3.1 are associated
with ASD in humans. A growing body of genetic, mathematical modeling, and pharmacological evidence
strongly suggests that small molecule potentiators/activators of Kv3.1 channel gating could promote PV-IN firing,
inhibitory output, and E/I balance. However, the dearth of potent and specific Kv3.1 channel potentiators with
suitable drug metabolism and pharmacokinetic (DMPK) properties has slowed efforts to critically evaluate the
therapeutic potential of Kv3.1 in treating ASD and schizophrenia. Here, we propose to employ a molecular target-
based drug discovery approach to develop 2-3 state-of-the-art Kv3.1 channel potentiators and then use them in
a mouse model of ASD to evaluate their ability to restore PV-IN excitability. In Aim 1, we will employ a fully
developed and validated fluorescence-based high-throughput screening (HTS) assay to interrogate
approximately 100,000 compounds from the Vanderbilt Institute of Chemical Biology library for novel Kv3.1
potentiators. Fluorescence and automated patch clamp electrophysiology assays will be used to identify potent,
selective, and chemically tractable compounds for further development. In Aim 2, an iterative cycle of medicinal
chemistry and functional assays will be used to optimize the potency, selectivity, and in vitro DMPK properties
of novel Kv3.1 potentiators. The studies outlined in Aim 3 will employ mouse brain slice electrophysiology to
evaluate the ability of optimized Kv3.1 potentiators restore PV-IN excitability in the nucleus accumbens and pre-
frontal cortex. We will specifically characterize the effects newly developed Kv3.1 potentiators on genetically
identified PV-IN current-voltage relationships, AP waveform, and firing frequency. This high-risk/high-reward
proposal will create unprecedented opportunities for pharmacologically modulating PV-IN excitability and
inhibitory output, critically evaluating the therapeutic value of Kv3.1 for modulating E/I balance, and potentially
impacting the clinical treatment of ASD and schizophrenia.

Public health relevance
NARRATIVE Autism spectrum disorder (ASD) and schizophrenia are associated with an increased ratio of excitatory-to- inhibitory (E/I) neurotransmission in brains of affected individuals, raising the possibility that therapeutics designed to restore E/I balance could be effective in treating these disorders. Fast-spiking parvalbumin (PV) GABAergic interneurons (PV-IN) are critical regulators of E/I balance and owe their ability to generate high- frequency action potentials in part to the restricted expression and function of Kv3.1 (gene KCNC1) voltage- gated potassium channels, mutations in which are associated with ASD in humans. Here, we propose to employ high-throughput screening, medicinal chemistry, automated and manual patch clamp electrophysiology, and electrophysiological recordings from identified PV-IN to develop a series of potent and specific Kv3.1 potentiators to restore E/I balance in ASD and schizophrenia.